Effects of mental health reimbursement increases in Medicaid on providers and patients

Project Summary
One in three Medicaid enrollees has a diagnosed mental health condition, yet this population faces substantial
mental health service gaps. Low Medicaid reimbursement is thought to be one key factor limiting the available
mental health specialists willing to accept Medicaid enrollees, contributing to these access gaps. However,
there have been strikingly few investigations on how payment amounts affect provider participation and
enrollee utilization and outcomes in Medicaid. Studies drawn mostly from primary care have yielded mixed
results, and it is unclear that findings in the primary care literature extend to mental health care, which faces
unique systemic and workforce constraints. Without rigorous study, policies using reimbursement to address
Medicaid mental health workforce shortages may fail to achieve their intended effects. Against these
knowledge gaps, we propose a 5-year mixed-methods research agenda that uses national Medicaid claims
data coupled with in-depth qualitative interviews to leverage a real-world natural experiment: beginning in
2022, multiple state Medicaid programs have implemented reimbursement increases for mental health services
in an effort to expand the mental health workforce and improve access to care. This explanatory sequential
mixed methods proposal thus focuses on key questions critical to policymakers: 1) to what extent do mental
health reimbursement rate increases change provider behavior and patient health, and 2) under what
conditions do they work well? In Aims 1 and 2, we use 2016-2025 national Transformed Medicaid Statistical
Information System (T-MSIS) Analytic Files (TAF), which provides comprehensive enrollee-level claims data
related to service utilization and prescription use. We use an event study difference-in-differences framework
to assess changes in outcomes for Medicaid enrollees exposed to reimbursement increases across
dimensions of magnitude (how large are rate increases?) and scope (to what services do rate increases
apply?). Aim 3 provides added explanatory depth on the policy heterogeneity of reimbursement rate increases,
through key informant interviews with state Medicaid administrators and mental health providers. We will select
up to 8 states where reimbursement increases are associated with improvements in Medicaid provider
participation (positive deviance states), and 8 states where they are not (negative deviance states). A number
of innovations, including assessment of policy heterogeneity across states, consideration of market factors and
claims-based measures of administrative burdens that influence provider decisions, and inclusion of both
psychiatrists and psychiatric mental health nurse practitioners, provide a comprehensive and robust
assessment of mental health rate increases, a key priority for state Medicaid programs and policymakers. In
collaboration with an advisory committee of Medicaid and mental health policy stakeholders, results will
provide actionable, impactful evidence to guide timely policies within a constrained mental health delivery
system.
1

Public health relevance
Project Narrative Low rates of Medicaid participation among mental health providers have compounded growing service gaps for the one in three enrollees diagnosed with a mental health condition, and states are actively implementing policies to address this critical problem. In this proposal, we use national Medicaid claims data, coupled with in- depth qualitative interviews, to evaluate the effects of mental health reimbursement increases on Medicaid participation among psychiatrists and psychiatric mental health nurse practitioners, and on health care utilization, quality, and clinical outcomes for enrollees. Findings from this study will generate new, actionable information for states seeking to expand the Medicaid mental health workforce, a key proposed lever to improve access to mental health services.